Experimental Therapeutics in Cancer Training Program

PROJECT SUMMARY/ABSTRACT
There is a significant unmet need to train both basic and clinical researchers in the skills needed to pioneer novel
translational research and develop the next generation of innovative cancer therapeutics. The proposed
Experimental Therapeutics in Cancer (ETC) training program will leverage the research and training strengths
of the Knight Cancer Institute (KCI), an NCI-designated Comprehensive Cancer Center at Oregon Health &
Science University (OHSU), to provide an immersive 2-year postdoctoral training program in oncological drug
development. OHSU was recently ranked among the top young universities in life sciences research in the world
in the Nature Index and, notably, OHSU and the Knight Cancer Institute are home to the Center for Experimental
Therapeutics (CET) that serves as a central hub for discovering and developing new cancer treatments to
improve patient outcomes. The ETC training program brings together resources and a multidisciplinary group of
preclinical and clinical mentors and trainees to accelerate the translation of scientific discoveries into effective
therapies. A key strength of the training program will be fostering collaboration and communication between the
basic and clinical science spheres. The program offers interprofessional training for PhD and MD postdoctoral
fellows with required co-mentorship by both basic and clinical faculty. We propose to train a total of 9 individual
PhD and MD scientists in this two-year program to position them for successful careers in translational oncology.
ETC trainees will participate in preclinical research projects focused on designing novel molecules, validating
therapeutic targets, performing lead optimization, developing biomarkers, and/or studying agents in preclinical
models. In addition to course work, including Drug Discovery and Development and Responsible Conduct of
Research, PhD and MD trainees will participate in clinical rotations and learn early phase trial design and related
regulatory requirements. The program emphasizes professional skills development, including oral and written
communication and grant preparation. Trainees will have a supported opportunity to develop mentorship skills
through mentoring a summer intern from one of the pathway programs at OHSU/KCI designed to increase the
participation of students from backgrounds underrepresented in biomedical research. The 37 training faculty in
the program have broad experience in oncology research, therapeutic development, and translational medicine.
ETC training faculty have outstanding track records in mentorship and research, with an average of
>$1,000,000/year in research funding. The ETC program is designed to train the next generation of translational
investigators in oncology with the necessary skills to translate preclinical research into novel therapeutics to
reduce the burden of cancer.

Public health relevance
PROJECT NARRATIVE The proposed Experimental Therapeutics in Cancer (ETC) training program at the OHSU Knight Cancer Institute will provide an immersive 2-year interprofessional postdoctoral training program in oncological drug development. The program fosters collaboration and communication between basic and clinical science spheres as the program will train both PhD and MD postdoctoral fellows with required co-mentorship by both basic and clinical faculty. Training includes multidisciplinary research experiences, specialized coursework, and professional skills development designed to train qualified translational scientists to think critically, transfer findings effectively between the basic and clinical spheres, and translate preclinical research into novel therapeutics to reduce the burden of cancer.